Targeting cancer neoantigens in patients with myeloid malignancies

Following my recent (July 24, 2022) appointment at the National Cancer Institute, Center for Cancer Research, I am currently in the process of establishing my lab within the Immune Deficiency Cellular Therapy Program. This includes acquiring key reagents and the necessary equipment and technology for carrying out my research and completing the required training. I am also taking steps to recruit a post-doctoral fellow or post-baccalaureate fellows. I anticipate initiating research studies before the end of the fiscal year.